Molecular Mechanisms of Auditory Transduction

Project Summary
The most fundamental event in the initiation of hearing is the conversion of sound into an electrical signal
by the opening of ion channels in hair cells. We know that TMC1 and TMC2 are the pore-forming subunits of
the mechanotransduction complex, we know the general tertiary structure of TMCs, and we know which
transmembrane domains constitute the pore. But we now need to know specifically how the sound-evoked
increase in tip-link tension leads to channel opening: how does PCDH15 in the tip link attach to TMC1, what
moves in TMC1 to open the pore, and how does tension propagate through the TMC channel to cause that
opening?
In this project we will first identify the parts of PCDH15 that bind to TMC1, using a combination of co-
immunoprecipitation, biolayer interferometry, protein biochemistry, site-directed mutagenesis, and single-cell
electrophysiology. Mutagenesis will be guided by cryo-electron microscopy of a related TMC channel and by
new atomic structures generated by structure-prediction software such as AlphaFold2. We will then identify
the parts of TMC1 that bind to PCDH15, using the same methods. In parallel, we will evaluate recent data from
other laboratories on regions of LHFPL5 that bind to TMC1.
To understand the gating of TMC1, we will use additional protein structure predictions from AlphaFold2
to identify different conformational states of TMC1 that may represent open and closed states of the channel.
Combining knowledge of the binding interface and the predicted gating transitions, we can use molecular
dynamics to determine whether and how the application of force—through either PCDH15 or LHFPL5—tends
to produce channel opening.
We will then test the models generated by molecular dynamics, by introducing cysteine residues at key
locations in TMC and transiently linking them with heavy metal ions or bivalent MTS reagents. These bridges
will lock TMC in one or another conformation. By expressing different cysteine mutants in hair cells and
applying these reagents while recording transduction currents, we can determine whether open or closed states
are favored, and thereby test the predicted gating movements. We will also test whether predicted movement
of an intracellular loop drives the gating movement, by inserting flexible peptide sequences.
This will generate an atomic-level understanding of mechanotransduction, unprecedented for hair cells
or for any eukaryotic force-gated ion channel. It will also provide deep insight into the function of TMC1 and
PCDH15, and how mutations in these proteins cause hereditary deafness.

Public health relevance
Project Narrative We will elucidate the most fundamental event in hearing: the conversion of a sound-induced mechanical stimulus into an electrical signal by the receptor cells of the inner ear. We will use a combination of biochemical, physiological and computational methods to understand how the mechanical stimulus is transferred from linking proteins, PCDH15 or LHFPL5, to an ion channel protein, TMC1, and to understand how the stimulus opens the ion channel in order to generate the electrical signal. This work will produce a fundamental understanding of one form of mechanosensation which can be applied to others such as touch, and will reveal mechanisms of pathophysiology caused by deafness-causing mutations.